Novel Quantitative MRI Techniques for the Assessment of Cardiac Fibrosis without Gadolinium Contrast

PROJECT SUMMARY/ABSTRACT
The clinical gold standard for the assessment of cardiac fibrosis is late gadolinium enhancement (LGE) cardiac
MRI (CMR), which is acquired using an inversion-recovery T1-weighted sequence, 10-to-20 minutes after the
administration of a gadolinium-based contrast agent (GBCA). Though LGE CMR is widely used in the clinical
assessment of myocardial infarction, viability and cardiomyopathies, there are several concerns about GBCA.
These include its association with nephrogenic systemic fibrosis (NSF) in patients with renal impairment;
allergic reactions to GBCA in some patients; and recently, concerns related to GBCA accumulation in the brain.
Thus, strategies for assessing myocardial fibrosis without administering GBCA are highly desirable.
Quantitative CMR techniques have received interest as alternatives for identifying myocardial fibrosis without
GBCA. Native T1 mapping has received attention, with studies indicating its utility in various cardiomyopathies.
Its main drawback has been its limited sensitivity, where the reported changes in T1 values from fibrosis has
been in a small range. Magnetization transfer (MT) imaging is another technique that has been investigated
through the MT ratio (MTR), which is a non-quantitative metric that depends on acquisition parameters.
Nonetheless, it has shown promising correlation with LGE, even when implemented through a simple ratio of
two images acquired with different balanced SSFP sequence parameters. T1ρ relaxation mapping, which is
based on rotating frame relaxations, maps motional regimes in the micro-to-millisecond scale and has also
shown promise, with histological confirmation in a swine model, as well as correlation with LGE in vivo.
However, its use in the heart has been limited to continuous-wave spin-lock preparation, making it susceptible
to magnetic field inhomogeneities, and limiting the range of macromolecular motion that it can assess.
In this proposal, we seek to develop novel quantitative CMR techniques to unleash the full potential of MT
imaging and rotating frame relaxation in assessing myocardial fibrosis. For MT contrast, we will extend beyond
MTR and quantify MT parameters, improving sensitivity and reproducibility. For rotating frame relaxations, we
will develop improved quantification techniques using adiabatic T1p, and higher order relaxations based on
Relaxation Along a Fictitious Field in the rotating frame of rank n (TRAFFn). These methods will allow probing of
a wide range of macromolecular motion regimes. Neither of our ideas on MT or rotating frame relaxation
imaging have been explored for imaging the human myocardium, but their potential has been highlighted in
other anatomies. Successful completion of this project has the potential to transform the way CMR is
performed for the assessment of myocardial fibrosis, eliminating the need for GBCA administration.

Public health relevance
PROJECT NARRATIVE Cardiac magnetic resonance imaging (MRI) is the clinical gold standard for the assessment of scar in the heart. However, cardiac MRI techniques require gadolinium based contrast agents (GBCA), which cannot be used in patients with kidney problems, and which recently caused concerns due to accumulation in the brain. In this work, we will develop novel cardiac MRI techniques to assess scar in the heart accurately and precisely without the need for GBCA.